Regulation of cellular functions by the plasminogen receptor, Plg-RKT

Project Summary/Abstract
The plasminogen activation system extensively regulates the inflammatory response in a broad range of
tissues. Inflammation is essential for maintenance of normal tissue homeostasis and its dysregulation has a
broad pathologic impact, including development of fibrosis, scarring, aberrant wound healing, infection, sepsis,
autoimmune disease and asthma. A critical gap in knowledge is understanding the mechanisms by which
plasminogen communicates with cells to regulate inflammatory responses. Plg-RKT is a novel integral membrane
protein that binds plasminogen via a C-terminal lysine exposed on the cell surface and promotes cell surface
plasminogen activation. The long-term goal of our laboratory is to understand mechanisms by which Plg-RKT
regulates physiologic and pathologic processes. This proposal is based on new data showing that Plg-RKT
promotes expression of CCL2, a key mediator of the pro-inflammatory response, and a potential intervention
point for the treatment of diseases with an inflammatory component. Additional results support the provocative
concept that regulation of CCL2 expression, rather than cell surface proteolysis of extracellular matrix, appears
to be the primary mechanism for plasminogen/Plg-RKT control of mononuclear cell recruitment in the
inflammatory response in vivo. The central hypothesis to be addressed is that plasmin(ogen)/Plg-RKT-
dependent promotion of CCL2 expression is the primary mechanism for promotion of plasmin(ogen)/Plg-RKT-
dependent mononuclear cell recruitment in the inflammatory response. The hypothesis will be tested in murine
models of pleurisy and peritonitis. And we will investigate the role of Plg-RKT in the inflammatory response in
asthma because in T helper type 2 (Th2) immune-related diseases, such as asthma, CCL2 is expressed at high
levels and its neutralization in animal models ameliorates disease. The objectives of this proposal are to
investigate the role of Plg-RKT in CCL2 synthesis in vivo and assess its impact on Plg-RKT-dependent
mononuclear cell recruitment and to examine the role of Plg-RKT in the pathogenesis of asthma. Our specific
aims are (1) to investigate the role of Plg-RKT in CCL2 synthesis in vivo and its impact on Plg-RKT-dependent
mononuclear cell recruitment and (2) to examine the role of Plg-RKT in the pathogenesis of asthma. We will use
Plg-RKT deficient mice and mice over-expressing Plg-RKT to test whether plasmino(ogen)/Plg-RKT-dependent
CCL2 up-regulation in vivo is PAR-1- dependent. We will use single cell RNA sequencing to identify cell types
responsible for Plg-RKT-dependent stimulation of CCL2 expression and we will determine whether exogenously
added CCL2 can rescue the impairment in macrophage recruitment in Plg-RKT-/- mice. We will investigate the
role of Plg-RKT in inflammation in ovalbumin-induced asthma and determine whether Plg-RKT regulates airway
hyper-responsiveness (AHR). We expect that accomplishment of our specific aims will establish Plg-RKT as a
pivotal regulator of the inflammatory response via regulation of expression of the key chemoattractant, CCL2,
and provide fundamental insights into how mononuclear cell recruitment is regulated.

Public health relevance
Project Narrative The proposed research is relevant to public health because new knowledge of mechanisms by which inflammation is regulated will be acquired. This knowledge is directly applicable to understanding the broad array of diseases with dysregulated inflammation, including, including aberrant wound healing, lung and cardiovascular fibrosis, scarring, infection, sepsis, autoimmune disease and asthma. In addition, the results of these studies may identify potential targets for development of new therapies for these diseases.